The evolutionary genetic basis for changes in viral receptor-binding specificities

Project Summary/Abstract
In this proposal, I discuss my plans to use a high-throughput yeast display platform to dissect the essential
changes that occur in viral protein binding specificities. I am using the coronavirus family for my investigations
because there are instances of species specificity changes of interest in the SARS-related coronaviruses that
are of interest, as well as instances of wholesale receptor changes in the MERS-related coronaviruses. Thus
far, this work has begun to find the substitutions of interest along the gains of human ACE2 binding in the
SARS-related coronaviruses. From preliminary results, we can see one substitution that is highly associated
with mutations that can bind human ACE2. In addition, I have started to parse out the important branch where
the wholesale receptor change occurred along the MERS-related coronavirus family phylogenetic tree. These
changes are particularly interesting because the evolutionary genetic basis for these receptor-binding
specificity changes has not been characterized. Through this research, I will inform the field of the necessary
changes that need to occur for viruses to switch receptors as well as what effects species specificity has on
these receptor binding dynamics. Overall, this work will be important for the field, too, because it will lay a
foundation of how these viruses are gaining the ability to spillover from their animal reservoirs and into
humans. Zoonotic transmission, or viruses gaining the ability to bind human receptors, is a major threat to
human health, as we know from the SARS-CoV-2 pandemic and the MERS epidemic, for instance.

Public health relevance
Project Narrative Pandemics have continually affected human health throughout history. Coronaviruses, both the MERS epidemic of 2012 and the SARS-CoV-2 pandemic of 2020 are no exception and demonstrate the danger they pose to humans. However, we do not know how to predict which coronaviruses will spill over into humans because we do not fully understand the receptor-binding specificities that underlie these viruses.